NCI Research Specialist (Clinician Scientist) Award

ABSTRACT
Dr. Karyn Goodman plays a critical role in Tisch Cancer Institute’s (TCI) cancer clinical trial program and
in supporting NCI-funded clinical trials. She has demonstrated a long-term commitment to this work
through her previous role as Associate Director (AD) of Clinical Research for 3 years at the University of
Colorado Cancer Center. In the same role in the TCI, Dr. Goodman has been able to further expand on
the work she was doing in Colorado and has focused on five major goals: 1) to expand access to clinical
trials across the Mount Sinai Health System (MSHS); 2) to increase the numbers of NCI-sponsored trials
performed across the MSHS; 3) to address the need for more oversight and integration of clinical trial
services provided across the MSHS; 4) to support junior faculty to develop investigator-initiated trials
(IITs) and present concepts to the Experimental Therapeutic Clinical Trials Network (ETCTN) for potential
support; and, 5) to increase minority recruitment to TCI clinical trials. Institutionally, she has been the
local PI of numerous National Clinical Trials Network (NCTN) studies at several NCI-designated cancer
centers and is currently the Mount Sinai PI for one ECOG/ACRIN trial and one ETCTN trial and serves as
the PI for the Early Drug Development Opportunity Program (EDDOP) at Mount Sinai. In addition, she is
a national leader in the NCTN both through her involvement in the GI committees of the Alliance for
Clinical Trials in Oncology and the NRG Oncology, as well as her role as the co-chair of the NCI
Gastrointestinal Steering Committee. She has nicely bridged the work she has done nationally with her
institutional AD of Clinical Research position. She brings her expertise in clinical trial development and
oversight which she gained as the National Study Chair of the CALGB/Alliance 80803, a Phase II trial that
evaluated PET-directed therapy for esophageal cancer, and the National Radiation Oncology Principal
Investigator of the RTOG/NRG 0848, a large Phase III trial investigating the role of adjuvant
chemoradiation in resectable pancreas cancer. Her overarching goal as a senior leader in the TCI is to
support the development of both IITs and NCI-funded cooperative group clinical trials that will further
advance the fight against cancer. The R50 funding mechanism will undoubtedly help foster her ability to
expand NCI-funded oncology clinical research at Mount Sinai Hospital and expand access to these trials
across the MSHS. Dr. Goodman is uniquely positioned for this award with both her institutional and
national service focused on developing and supporting cancer clinical research.

Public health relevance
NARRATIVE The Tisch Cancer Institute (TCI) seeks to support the work of Dr. Karyn Goodman, Associate Director of Clinical Research, to foster the growth of our NCI-designated cancer center’s clinical trial program and improve patient access to NCI-sponsored clinical trials across the Mount Sinai Health System. By expanding the clinical trials footprint, the TCI can extend the reach and impact of our high-quality, cutting edge cancer care to the entire catchment area of New York City. Greater access leads to improved equity and inclusion for our diverse patient populations.